Hispanic Alliance for Clinical and Translational Research (Alliance)

Hispanic Alliance for Clinical & Translational Research (Alliance)
ABSTRACT
Improving health care for the medically underserved, including our Hispanic population, afflicted by prevalent
diseases, such as cancer, cardio-metabolic and infectious diseases, remains a major challenge. The current
supplement application is to support the development of Hispanic Alliance for Clinical & Translational Research
in Puerto Rico (Alliance), which aims to build on the existing infrastructure of the Puerto Rico Clinical and
Translational Research Consortium (the Alliance, PR-CTRC) and the unique expertise on emerging infectious
diseases and strategic positioning for the study of disaster-related conditions and their impact on Health. The
Alliance expands the scope of our successful decade long partnership by leveraging intellectual and physical
resources of the three major academic health sciences centers on the Island: the University of Puerto Rico
Medical Sciences Campus, the Universidad Central del Caribe, and the Ponce Medical School Foundation and
key-collaborating institutions to support an integrated, island-wide program dedicated to the conduct clinical and
translational research. The Alliance is founded on our hypothesis that research-driven improvements in health
outcomes requires an integrated network of key stakeholders representing academia, government, community -
based organizations, and health care delivery systems working together in an interdisciplinary, multi -sectorial
clinical- translational research model. The objective of the Alliance is to serve as the catalytic center to enhance
the competitiveness of investigators to conduct research and obtain additional funding for clinical and
translational research addressing highly prevalent diseases and those that affect the medically underserved in
PR. The long-term goal of the Alliance is to transform clinical and translational research in Hispanic populations
in the mainland and in Puerto Rico by promoting inter-disciplinary collaboration and leverage of resources to
address diseases affecting Hispanic communities.

Public health relevance
Project Narrative The Hispanic Alliance for Clinical and Translational Research is relevant to public health as it helps advance our fundamental knowledge of ethnic-specific factors that could explain the disproportionate burden of certain diseases, and the limited or lack of effective treatment for this ethnic subgroup, which is increasingly represented in the US mainland population. The long-term goal of the Alliance is to transform clinical and translational research in Hispanic populations in the mainland and in Puerto Rico by promoting inter-disciplinary collaboration and leverage of resources to address diseases affecting Hispanic communities. The project is relevant to the NIH mission because it will contribute with training the next generation of scientists, develop research capacities, and will enhance the diversity of the scientific workforce.